Endothelial Beta 1-integrins in Cerebral Vascular Barrier Integrity

Ischemic stroke acutely targets the cerebral microvasculature. Within hours following proximal MCA occlusion,
the microvessel endothelial permeability barrier opens causing “vasogenic” edema in the corpus striatum. This
process is not fully understood and has no treatment currently. Cerebral microvessel structure and signaling
appears central to these acute changes. Interfering with the established adhesion of endothelial cell β1-
integrins to the underlying matrix acutely increases T2 but not ADC by 14T MRI within 6 hours, and acutely
increases permeability in vitro, alters tight junction (TJ) expression, and alters F-actin conformation, without
loss of endothelial cell viability. However, inhibition of myosin light chain (MLC) phosphorylation, within 6 hours
in vitro, prevents the permeability increase when established β1-integrin–matrix adhesion is disrupted. Hence,
modulating endothelial β1-integrin signaling acutely could preserve the barrier and decrease striatal edema.
The hypotheses to be tested in this proposal state that i) interactions of microvessel endothelial cells with their
basal lamina matrix proteins through β1-integrin adhesion receptors are a major structural and signaling
determinant of blood-brain barrier behavior, ii) focal ischemia disrupts stable β1-integrin–matrix interactions, iii)
disruption of these interactions increases microvessel permeability, and iv) this acutely increased permeability
and edema can be prevented by inhibiting β1-integrin signaling. The three Specific Aims will demonstrate
that: 1) rapid modulation of the MLC and associated β1-integrin signaling can prevent the acute permeability
increase caused by interference with β1-integrin–matrix adhesion, 2) experimental ischemia disrupts
endothelial cell β1-integrin–matrix adhesion, induces endothelial signaling that increases permeability, and this
can be prevented, and 3) focal ischemia, through tissue injury, decreases β1-integrin expression or matrix
adhesion, and increases endothelial permeability, which can be prevented. A central role for endothelial cell
β1-integrin–matrix adhesion as the determinant of acute “vasogenic” edema in focal ischemia is conceptually
novel and testable. With high-quality primary cerebral endothelial cell cultures from wild type and conditional
endothelial β1-integrin knockout constructs to define β1-integrin signaling events (Specific Aim 1), in vitro
models to quantify the effects of ischemia on endothelial cell β1-integrin signaling (Specific Aim 2), and real-
time assessment of acute edema formation in murine stereotaxic injection and MCA occlusion models using
real-time 14T MRI to guide acute assessments of permeability and its prevention with signaling inhibitors
(Specific Aims 1 and 3), this Project will demonstrate that β1-integrin–matrix adhesion is pivotal to edema
prevention. These very feasible studies are a new direction in stroke research that will substantially further our
understanding of acute blood-brain barrier behavior under focal ischemia. Understanding β1-integrin signaling
mechanisms is also likely to identify novel specific targets to preserve or selectively change endothelial barrier
function in other neurovascular disorders, with the aim to improve outcome.

Public health relevance
PROJECT NARRATIVE Ischemic stroke is a devastating disorder that quickly disrupts important bonds between the endothelial cells that line the blood vessels of the brain, bonds that protect the brain from swelling, leakage of blood, and increased injury. We have recently found that molecules (β1-integrins) that glue the endothelial cells to their scaffolding (matrix) in the blood vessel wall are essential for maintaining the bonds between endothelial cells, and that ischemic stroke quickly disrupts β1-integrins, thereby causing leakage into the tissue in the first hours of stroke. This research project will define the exact mechanisms by which endothelial cell β1-integrin–matrix interactions are acutely broken, how the loss of endothelial β1-integrins contributes to brain swelling during ischemic stroke, and how these acute events can be prevented, thereby offering new acute treatment strategies for stroke.